Restorative practice in repairing harm and promoting safe and inclusive practices in the laboratory.

Project Summary: Trainees who are underrepresented in the biomedical research enterprise report negative marginalizing experiences that lead them to leave academic research environments. Many such experiences are not addressed by existing reporting mechanisms since they do not rise to the level of policy violation, even though such incidents cause great harm and disrupt learning, health, and safety. Simultaneously there is a significant lack of information around the types and prevalence of bias and diversity-themed incidents to inform the development of interventions that would prevent harm and support trainees, and there is no mechanism for repairing this harm. We propose an institutional collaboration between Student Life Services, the Office of Diversity and Outreach, the Graduate Division, Student Health and Counseling Services, and eight NIGMS- funded training grant programs to pilot a (1) centralized mechanism for trainees to share their everyday experiences of bias; (2) the use of restorative justice approaches in addressing, repairing, and preventing racial harm in the basic science training environment, and (3) the development of a program of training to prepare future practicing psychologists to more effectively meet the needs of graduate student trainees. The proposed program will serve as a pilot for efforts to develop an institutionalized Bias Response program for the wider doctoral and postgrad population at UCSF, and will provide a roadmap for other institutions seeking to promote safe and inclusive biomedical research training environments.

Public health relevance
Project Narrative: The proposed program will seek to develop, deliver, and evaluate the impact and value of restorative justice approaches to addressing student-reported incidence of bias and other diversity-themed incidents, and develop interventions that prevent future incidents and promote safe and inclusive biomedical research training environments.